PROTEOMICS AND BIOINFORMATICS CORE

The Proteomics and Bioinformatics Core of the University of Washington Diabetes Research Center provides
affiliate investigators the powerful tools of modern mass spectrometry (MS) and complex data set analysis. The
goals of the Core are to: (1) Perform MS for unbiased discovery and semi-quantitative analyses of complex
protein samples using state-of-the-art untargeted and targeted LC-MS/MS techniques for both qualitative and
quantitative analysis, including development of new MS methods for structural identification; (2) Provide
validated targeted quantitative assays of specific protein analytes relevant to diabetes in support of clinical and
translational studies; (3) Assist DRC affiliates with experimental design of their studies to ensure successful
proteomics analysis and provide training in principles and use of MS; and (4) Provide bioinformatics analysis
(e.g., differential expression analysis, protein-protein interaction network analysis, and pathway enrichment
analysis) for proteomic and transcriptomic data sets, including RNA-seq and single cell RNA-seq, with the aim
of providing an integrated, systems biology overview of diabetes and diabetes-related disease processes. By
providing a centralized facility and expertise necessary to perform state-of-the-art proteomics analysis,
quantitative mass spectrometric assays, and bioinformatics analysis, the Core meets these goals with optimal
efficiency and cost-effectiveness in support of basic and clinical research. Further, by centralizing and
standardizing procedures, the Proteomics and Bioinformatics Core provides its affiliate investigators a common
set of analytical tools for obtaining a unified understanding of molecular mechanisms involved in
pathophysiologic processes of diabetes and its associated complications.